Engineering Injectable Microporous Hydrogels for Diabetic Wound Repair

PROJECT SUMMARY
In this proposal, we aim to engineer a biomaterial scaffold to accelerate diabetic wound closure by improving upon a
new sub-class of hydrogel biomaterials we have invented called Microporous Annealed Particle gel or MAP gel. MAP
gels are composed of microscopic spherical building blocks made using microfluidic generation and assembled in situ to
form a stable MAP scaffold. MAP scaffolds have been shown to improve tissue healing in both skin and brain through a
porosity-dependent reduction in wound inflammation and promotion of cell/tissue integration. We are focusing on
material improvements to counter three known difficulties for material-based treatment of diabetic wounds: abnormally
high immune activation, increased degradative microenvironment, and diminished new tissue generation. Specifically, we
have identified three MAP properties that we can independently modulate for scientific optimization: pore geometry
(known immunomodulatory parameter), degradability (premature material degradation results in loss of porous
geometry), and heterogeneous heparin “micro-islands” (a novel material strategy we have developed to improve intra-
scaffold angiogenesis). We hypothesize that investigating and optimizing each property individually will accelerate
diabetic wound closure and, finally, that the optimized properties can be combined synergistically.
We will evaluate and optimize each material property using the following characterization workflow: in vitro property
quantification (property-dependent), in vitro cell response (survival, proliferation, and migration), in vivo immune
response (analysis by FACS), in vivo material degradation (analysis by histology), and in vivo tissue healing/regeneration
(analysis by immunohistology). Our studies focus on the diabetic wound environment through use of dermal cell lines in
vitro and a diabetic mouse (db/db) splinted wound healing model. Each Aim of our approach isolates an individual
material property to simplify the investigation. For example, pore geometry impact is investigated using a single hydrogel
formulation and hydrogel formulation impact uses a single pore geometry (constant formulation and pore geometry taken
from our successful non-diabetic studies). If successful, this project will provide a better understanding of tissue response
to a new class of biomaterial and produce an inexpensive and effective scaffold treatment option for accelerating diabetic
wound closure.

Public health relevance
PROJECT NARRATIVE This project aims to gain a better understanding of and improve a new sub-class of wound healing biomaterial that has shown great promise in the treating of non-diabetic wounds. The goal of this project is to ensure that the material is optimized for improved healing by improving qualities associated with its wound interactions: minimizing inflammation, resisting premature scaffold degradation, and promoting new tissue formation.